Dual targeting of cGAS-STING and splicing to prime lung cancer immunogenicity

Project Summary
Lung cancer is the leading cause of cancer-related death in the United States. Non-small cell lung cancer
(NSCLC) is the most common type of lung cancer and despite aggressive treatment strategies that include
medical therapy, surgical resection, and radiation therapy, 5-year survival rates for patients with lung cancer
remain dismal. Recently, the US Food and Drug Administration (FDA) approved several immune checkpoint
inhibitor-based therapies for the treatment of NSCLC, establishing immunotherapy as an effective therapeutic
option and standard-of-care treatment for NSCLC. Despite this, many patients fail to respond to immune
checkpoint blockade (ICB) and the subgroup of patients with KRAS and STK11 commutations (KL) has
emerged as a particularly aggressive, immunosuppressive form of NSCLC resistant to ICB. Our group has
recently discovered that by treating KL-mutated NSCLC with epigenetic de-repressing agents, expression of a
key protein in the immune response against lung cancer, stimulator of interferon genes (STING), is restored.
When stimulus for the STING pathway is subsequently provided through pulsed inhibition of a spindle
assembly checkpoint protein, monopolar spindle 1 (MPS1), potent anti-tumor responses occur, restoring
sensitivity to ICB. While these findings have yet to be validated in clinical samples of KL-mutated NSCLC,
these samples are now available to use for study. Validation of this therapeutic strategy will show that it is
possible to overcome KL-mutation induced immunosuppression, though, it does not generate neoantigens to
drive durable anti-neoplastic immune responses. Fortunately, MPS1 shares kinase homology with CDC2-like
kinase (CLK2), a key regulator of mRNA splicing, and dual MPS1/CLK2 inhibitors have been developed. This
provides the unique opportunity to additionally dive durable anti-tumor immune responses through
simultaneous pharmacological disruption of mRNA splicing. Indeed, pharmacological modulation of splicing
was recently demonstrated as a definitive, untapped method to generate neoantigens that elicit anti-tumor
immune responses. The overall goal of this fellowship proposal is, therefore, to provide advanced post-doctoral
training in translational cancer immunotherapy research while evaluating a novel approach to enhance
immunogenicity in a highly aggressive and resistant form of NSCLC. We will accomplish this by (1) validating
the effect of epigenetic de-repression of STING and pulsed MPS1 inhibition in clinical samples of ICB-resistant,
KL-mutated NSCLC and (2) examining mRNA splice disruption and neoantigen generation in dual MPS1/CLK2
inhibitor treated KL-mutated NSCLC. Together these aims will seek to improve therapeutic outcomes for
patients with NSCLC while enhancing the pool of highly trained physician-scientists.

Public health relevance
Project Narrative With a focus on post-doctoral training, this proposal aims to advance a novel approach for the treatment of a highly aggressive form of lung cancer. In addition to enhancing the pool of highly trained physician-scientists, the results of this study will validate a novel approach to enhance cancer immunogenicity. This may be useful in treating many forms of cancer, thus improving public health and quality of life for patients.